Defining the role of mutational burden in sustaining normal homeostasis during aging

Project Summary

My lab is interested in the mechanisms that maintain tissue homeostasis, which is critical for proper organ
function throughout our lifetimes. Mutations are thought to disrupt cell behaviors and homeostasis, and thus lead
to disease. However, recent work demonstrated that aged but phenotypically normal tissues, including skin blood
and intestine, are a mosaic of distinct wild-­type and mutant clones. Strikingly, 20-­30% of cells bear cancer-­
associated mutations. Intriguingly, we and others have shown that cells containing just one of these cancer-­
associated mutations outcompete neighboring wild-­type cells in the skin. The mechanisms that tolerate but also
restrict multiple mutant clones within in aged tissues are not known.
We hypothesize that the accumulation of diverse mutant clones promotes healthy aging, as long as their
clonal outgrowths are confined, and homeostasis is maintained. Mutations have long been equated with the
emergence of pathology and therefore as deleterious alterations that must be eradicated. The high frequency of
mutant cells within our normal, aged tissues would imply a continuous and energetically consuming investment
to counter their putative negative consequence. Alternatively, mutant cells, particularly those carrying mutations
that enhance proliferation/growth, might support or even help tissues maintain homeostasis during aging. Our
unconventional hypothesis predicts that tissues benefit from the increased growth introduced by low-­
level genetic heterogeneity. We propose that a balance is achieved by activation of a mechanism that
suppresses aberrant expansion but tolerates and positively utilizes mutant subpopulations. In this scenario,
disease arises only after a threshold for tolerance is exceeded, either due to loss of the protective mechanisms
or due to an excessive mutational burden.
In this Pioneer proposal, we will combine our unique ability to capture behaviors in an intact mammal, to
now define the molecular and metabolic consequences of mutations and aging. Understanding how cells evolve
their gene expression and metabolic activities in the presence of accumulating mutations and as tissues age will
provide fundamental insights into how organs adapt and remain functional throughout our lifetime.
Completion

of the proposed work will reveal the mechanisms aging skin uses to constrain mutant subpopulations and how
acquired mutations in turn impact the aging of skin. These findings could transform our strategies to treat cancer,
which are currently aimed at eliminating all mutant cells – which we predict would have unintended, adverse
outcomes. The proposed work will shed light not only on tissue homeostasis but also on the problem of aging,
which is the major risk factor for nearly every chronic disease.

Public health relevance
Project Narrative Our tissues continuously accumulate mutations and yet they do not develop cancer at the rate predicted by their mutational burden. This innovative proposal builds on a bold hypothesis that accumulated mutations contribute to healthy aging. This research will have a high impact on defining the link between aging and cancer, and will provide new molecular and cell biological insight into the role of mutations in mammalian skin homeostasis during aging.